BRYOSTATIN 1 (NSC 339555) &FLUDARABINE IN LYMPHOCYTIC LEUKEMIA

To determine the toxicities and appropriate doses for the combination of bryostatin and fludarabine in the treatment of chronic lymphocytic leukemia and indolent lymlphoma